Mechanisms controlling retinal responses to natural stimuli

We have made a tremendous amount of progress understanding sensory function. But this understanding fails
to account for responses to natural stimuli. We propose to develop a mechanistic understanding of how natural
stimuli are encoded in the primate retina through a combination of directed experimentation and quantitative modeling. This will encompass three aims: (1) determining the circuit mechanisms that explain striking differences in
responses of On parasol ganglion cells to natural and artiﬁcial stimuli; (2) determining the origin, properties, and
functional signiﬁcance of the receptive ﬁeld surround of retinal ganglion cells; and, (3) developing and applying
new tools to reveal the importance of cone adaptation in shaping ganglion cell responses to natural stimuli.

Public health relevance
Our understanding of how retina neurons works fails to account for responses to natural images - the stimuli for which the system evolved to work. The proposed work will improve our understanding of this issue. This is a requisite step in identifying the role of key circuit mechanisms in normal and aberrant natural vision and in the design of devices such as retinal prostheses to replicate or replace the retina.